2016 Biology of Acute Respiratory Infection Gordon Research Conference & Gordon Research Seminar

? DESCRIPTION (provided by applicant): Project Summary Acute respiratory tract infections account for substantial morbidity and mortality worldwide. The changing demographics of the population at risk, combined with the emergence of new and resistant microbial pathogens suggest that the burden of disease will almost certainly worsen. The 2016 Gordon Research Conference (GRC) on Biology of Acute Respiratory Infection will highlight new paradigms in lung infection, including novel insights into pathogen recognition and cellular participants involved, antimicrobial effector mechanisms, regulation of lung injury and repair in respiratory infection, the development of lung immune memory, emerging respiratory pathogens, the lung microbiome in health and disease, mechanisms of microbial pathogenesis, genetic and environmental regulation of the host response, and strategies for the prevention and profiling of the host response in patients with acute respiratory tract infections. An international group of experts have been assembled to provide cutting-edge overviews of these rapidly evolving fields. The GRC on Biology of Acute Respiratory Infection and associated Gordon Research Seminar provide an ideal venue for the creative and dynamic exchange between a multidisciplinary group of basic biologists, translational scientists, and clinical investigators. A fundamental understanding of basic mechanisms involved will foster the development of innovative approaches to the diagnosis, prevention and treatment of serious infections of the respiratory tract.

Public health relevance
PUBLIC HEALTH RELEVANCE Project Narrative Acute lung infections are a major cause of morbidity and mortality, associated with a greater number of deaths each year in the USA than HIV/AIDS and cancer combined. The purpose of this conference is to provide a forum for investigators who study acute lung infections to better understand microbial pathogenesis and the intricacies of the immune responses evoked which cause much pathology. This Gordon Research Conference and associated Gordon Research Seminar will provide an opportunity to share new hypotheses, discuss novel approaches and establish collaborations to better understand the pathogenesis of lung infection and hopefully develop better strategies for prevention and treatment.